Neuroimaging of the schizophrenia-associated 3q29 deletion

SUMMARY
3q29 deletion syndrome is caused by a recurrent typically de novo 1.6 Mb heterozygous deletion
and is associated with a range of neuropsychiatric phenotypes, including mild to moderate
intellectual disability, autism, anxiety, and a 40-fold increased risk for schizophrenia. Although the
3q29 deletion is rare (~1 in 30,000 births), its high risk for neuropsychiatric phenotypes coupled
with its relatively low complexity (22 genes in the deletion interval) suggest the pathophysiology
may yield to interrogation. Studies of the molecular, cellular, and behavioral consequences of the
deletion, in both human patients and model systems, are underway by our group and others.
However, disturbances in brain structure and function are not yet articulated, and we propose to
investigate them using structural, diffusion, and resting-state functional MRI. This is the first
neuroimaging study of the 3q29 deletion. To accomplish our aims, we have established the
Emory 3q29 Project (http://genome.emory.edu/3q29/), where the overarching goal is to
understand the basis of 3q29 deletion-associated phenotypes. We have also created the 3q29
deletion registry (3q29deletion.org), where despite the low population frequency of the deletion
(1 in 30,000) we have ascertained over 100 carriers (ranging in age from 1.5 – 34 years), the
largest cohort ever assembled. This infrastructure, along with our existing NIH-funded grant
(“Modeling the Human Neuronal Phenotype of the Schizophrenia-Associated 3q29 Deletion,” MPI
Mulle/Bassell, 1 R01 MH110701), allows us to conduct in-person phenotypic assessments of
3q29 deletion patients, generating a rich set of behavioral and clinical data. This existing effort,
while exciting, lacks integrated collection of data at the level of brain systems. We propose adding
this additional dimension of data collection to our ongoing effort in order to identify volumetric,
structural connectivity, and functional connectivity alterations that are characteristic of 3q29
deletion syndrome. We will also perform a comparison between 3q29 deletion and another variant
with an extremely high risk for schizophrenia, the well-known 22q11.2 deletion. Defining the
impact of the 3q29 deletion on brain systems may serve as a fundamental link bridging molecular
deficits and behavioral manifestations.

Public health relevance
NARRATIVE 3q29 deletion syndrome is caused by a deletion of DNA, sized 1.6 million bases, and is associated with high risk for intellectual disability, autism, anxiety, and schizophrenia. We propose to characterize and quantify volumetric, structural connectivity, and functional connectivity alterations among 3q29 deletion individuals as compared to typical controls, the first ever study of this kind in 3q29 deletion syndrome. This project will help us to understand the core pathophysiology underlying neurodevelopment and neuropsychiatric phenotypes.